Molecular Mechanisms in Sweat Gland Development

PROJECT SUMMARY
Eccrine sweat glands are the most abundant gland in human skin and are essential for thermoregulation. Human
patients suffering from severe burns and sweating deficiency lose their ability to regulate body temperature,
which make sweat gland regeneration a critical and immediate next goal in stem cell therapeutics. However,
very little is known about the molecular mechanisms involved in the sweat gland development and the regulation
of the epidermal progenitors that give rise to sweat glands. This proposal is built upon my previous work on the
identification of multipotent stem cells in the sweat glands and the molecular signaling events that specify the
sweat gland fate. Using the novel strategies that I had established to study sweat glands, I aim to investigate the
mechanical and signaling pathways that further shaped the morphogenesis of sweat duct and gland, with a
combination of technologies including microengineering technologies, mouse genetics, immunofluorescent
confocal and light sheet microscopy imaging, single cell RNA- and ATAC-sequencing, Fluorescent Activated
Cell Sorting, and tissue explant and cell culture systems. This proposed research plans upon completion will
provide significant insights into spatiotemporal control of the signaling environment for epidermal progenitor to
specify their cell fate of duct vs gland during development. Our studies will significantly impact on the field of
sweat gland biology and facilitate the development of novel strategies for future sweat gland regeneration for
patients in need.

Public health relevance
PROJECT NARRATIVE Human patients suffering from sweat gland deficiencies are unable to properly maintain body temperature, which can lead to hyperthermia, heat stroke, brain damage, and potentially death. We will investigate the molecular mechanisms underlying sweat gland development at different stages and how the progenitor cells respond to environmental cues which shape the morphogenesis. Upon completion our work will significantly advance our knowledge in sweat gland biology, as well as facilitate development of novel strategies to regenerate sweat glands for the patients who loss sweating ability to regain thermoregulation.